Mechanisms of T cell activation in cardiac fibrosis and non-ischemic heart failure

While great strides have been made to diversify the health sciences professions, there are still a
disproportionately low number of individuals from underserved groups entering the biomedical
sciences. This research supplement is submitted with the strong conviction that by offering
advanced education and training opportunities in a thriving biomedical research environment, we
can increase the participation of individuals currently underrepresented in the biomedical
sciences. The proposed research plan and strategy build up on findings from the parent R01
HL144477 that expand to new studies not proposed in the parent grant, which have never been
reviewed or deleted by the initial review group and are a logical extension to discover new
mechanisms of cardiac T cell mediated inflammation and fibrosis in non-ischemic heart failure,
which will result in an integral part of the parent R01. The present research plan and strategy will
be a central component of an enriching diversity supplement experience for Maria Zambrano, a
motivated graduate student who will perform all the proposed studies to test new hypotheses in
the field of cardiac fibrosis (CF) and T cell inflammation. Maria will use tools developed in the
parent grant and in vitro and in vivo experimental approaches to investigate the role of cardiac-
fibroblast crosstalk in chemotherapy induced cardiomyopathy,

Public health relevance
Narrative Inflammation and cardiac fibrosis are central to the initiation and progression of heart failure and cardiomyoapthies, leading causes of death and hospitalizations worldwide. Results from this proposal will provide ground for the identification of inflammatory and fibrotic mechanisms in chemotherapy induced cardiomyopathy.